Cochrane Complementary Medicine Field: Resource for Research

PROJECT SUMMARY
Cochrane is an international nonprofit organization with the mission to improve health-related
decisions by preparing, maintaining and promoting the accessibility of systematic reviews. The
Complementary Medicine Field is the Cochrane group that is focused on supporting the
production and dissemination of Cochrane systematic reviews of complementary and integrative
medicine therapies. The Field is based within and sponsored by the Center for Integrative
Medicine at the University of Maryland, under the direction of Brian Berman, who co-founded
the Field in 1996. Over the past 20 years, the Field has been supported through an R24 grant
from NCCIH. The Field has used this R24 grant to significantly advance NCCIH's objective to
develop and disseminate the ‘current best evidence’ on complementary and integrative health to
support decision-making on the part of patients, health care practitioners, policy makers, and
research administrators. However, many questions about the usefulness and safety of
complementary therapies do not yet have relevant, up-to-date, and actionable answers, and
there is a need to continue the rigorous development, effective dissemination, and incorporation
into practice of high quality, objective information on complementary and integrative therapies.
To further expand the Complementary Medicine Field as a resource for research, this proposed
renewal of our R24 grant has the following 4 specific aims: 1) Improve and increase the
database of controlled trials of complementary medicine interventions; 2) Increase the number
of high quality, high priority, up-to-date systematic reviews in complementary medicine; 3)
Increase the relevance, usability and accessibility of the Complementary Medicine Field
resources and research evidence to patient, clinical, and research stakeholders; and 4) Promote
international collaboration by contributing to the Cochrane organization.
Since its founding, the Field has displayed a high level of productivity in our trial database
development, systematic review production, and methodological work. The Field will continue its
productivity in these areas and increase effective prioritization and knowledge translation of its
products, supported by the Cochrane research and dissemination infrastructure and the
worldwide complementary medicine network developed by the Field over the previous 20 years.

Public health relevance
Project Narrative RELEVANCE Systematic reviews of controlled trials are considered the gold standard for evaluating the effectiveness of healthcare interventions, including complementary and integrative therapies (CAM). The availability of relevant controlled trials is crucial for the conduct of these systematic reviews, and Cochrane has been in the vanguard of controlled trial database development and systematic review methods since 1992.1-3 This grant will support the Cochrane Complementary Medicine Field in developing and expanding our database of CAM controlled trials and in preparing and disseminating high priority, high quality CAM systematic reviews.